Transforming mental health care via science-based, personalizable and scalable digital therapeutics

Project Summary_Abstract
Mental health problems are increasing worldwide; however, the vast majority of people struggling with
mental health challenges do not receive any treatment and the mental health workforce is woefully insufficient
to meet our population-level needs. Digital Therapeutics (DTx) are optimally positioned to tackle these
challenges and transform mental health care. DTx are clinical-grade software used to prevent, treat, or
manage a medical disorder or disease. DTx can have a major impact on health costs, health behavior, and
health outcomes. For example, DTx can effectively treat depression, anxiety, ADHD, panic disorder and eating
disorders, among many other mental health conditions. And, they are associated with marked reductions in ED
visits, inpatient utilization, and net costs, and increases in medication adherence.
Despite their impressive clinical value, several challenges persist in fully realizing the potential of DTx
to improve people’s lives globally. First, the pace at which DTx are developed, tested, and commercialized is
slow. Second, many development activities are redundant across projects. Third, due to budget, time and
capacity constraints, many scientists develop prototypes of DTx that can be used in research but which are not
built to scale for large numbers of users. Finally, most DTx cannot be readily modified for various populations
critical for advancing digital health equity (adapted to culture, language, race, ethnicity, sexual orientation).
Based on over two decades of NIH-supported work developing, evaluating and commercializing DTx, we
have developed a unique DTx platform (Laddr) which integrates science-based, therapeutic processes to
address a wide range of behavioral problems within a single digital platform. This platform offers the potential
to revolutionize digital health - as it provides a scalable model for delivering DTx to treat any disorder with a
behavioral component. We now plan to make an editable version of Laddr (called Cogito) commercially
available to developers of DTx. Cogito will provide a turnkey solution for rapidly developing, evaluating,
deploying, and scaling DTx for the prevention, treatment and/or management of any disease or disorder - via a
drag and drop interface with no programming necessary.
In this Phase 1 SBIR application, we will finalize several features of the Cogito platform to increase its
commercial potential as a turnkey platform for developing and hosting DTx. And we will assess the feasibility,
technical merit, and commercial potential of the Cogito DTx platform via usability testing with clinical
researchers. We will focus on the usability of Cogito with researchers in the mental health field in this initial
phase and then expand to a broad clinical research community focused on the prevention, treatment, or
management of various health conditions in future iterations of this work.
to markedly accelerate the pace and impact of science based DTx.
Overall, Cogito offers great promise

Public health relevance
Project Narrative The proposed project will be the first to commercialize a unique transdiagnostic digital therapeutics development and hosting platform grounded in the science of behavior change for any population. This will replace the currently time- and cost-inefficient processes of developing digital therapeutics and rapidly accelerate the pace at which science-based digital therapeutics can transform healthcare.